Growth Hormone Regulation of SH2B1

DESCRIPTION (provided by applicant): Exciting recent genetic studies implicate the scaffold protein SH2B1 in human disease. Human mutations in SH2B1 are associated with severe early onset obesity with disproportionately severe insulin resistance, impaired brain development, and, in some cases, short stature. This phenotype (strikingly similar to that of SH2B1-/- mice) is consistent with SH2B1 being a signaling molecule for multiple ligands, including growth hormone (GH), leptin, and insulin. SH2B1 is recruited to JAK2 and is a critical component in GH regulation of the actin cytoskeleton, a prerequisite for cellular proliferation, differentiation and migration. However, the mechanism by which SH2B1 facilitates GH-induced changes in the actin cytoskeleton remains largely unknown. The long-term goal is to understand the mechanism by which SH2B1 contributes to the function of GH and other ligands, and to gain insight into unrecognized cellular actions of GH; new functions of SH2B1; and how scaffold proteins such as SH2B1 move highly regulated and dynamic complexes from membrane-bound receptors to multiple, often remote, sites in the cell (e.g., focal adhesions, lamellipodia, cytoplasm, nucleus). The objective of the current proposal is to understand how SH2B1 regulates assembly and movement of signaling complexes and whether dysregulation of these functions contributes to defects in cellular function and ultimately human obesity, insulin-resistance, neurologic disorders, and suppressed growth. The central hypothesis is that SH2B1 facilitates the formation and/or movement of SH2B1 signaling complexes to specific locations in the cell (e.g., pm, lamellipodia, cytoplasm, nucleus) in response to GH. These functions of SH2B1 enhance GH regulation of the actin cytoskeleton, GH-induced motility, and GH responses in the nucleus. They are critical to normal human physiology, such that their impairment due to mutation contributes to the dramatic phenotype observed in human patients. Guided by strong preliminary data, this hypothesis will be tested by pursuing three specific aims: 1) Elucidate the mechanism by which SH2B1 reversibly localizes to the plasma membrane, cytosol and nucleus. 2) Determine the role of SH2B1 in regulating GH-induced changes in the actin cytoskeleton, cell motility, and trafficking of proteins between intracellular compartments. 3) Determine the functional consequences of mutations in SH2B1 associated with human disease. Experiments will use a combination of biochemical, immunologic, cell biology, and imaging techniques standard in the lab. State-of-the-art microscopes, photoactivable probes, proteomics, cell lines and both primary macrophages and MEFs from SH2B1-/- mice, will also be used. The concept that the nuclear localization signal of SH2B1 is a dual function motif that mediates both nuclear import and plasma membrane binding that is regulated by phosphorylation of nearby serines is innovative. The proposed research is significant because it will provide insight into the role of SH2B1 in the function of GH and the numerous other ligands (e.g., leptin, insulin, nerve growth factor) that utilize SH2B1 as a signaling protein.

Public health relevance
PUBLIC HEALTH RELEVANCE: These studies will provide insight into the role of a multifunctional adapter protein SH2B1 in the function of growth hormone and the many other cytokines, hormones and growth factors (e.g. leptin, insulin, nerve growth factor) that use SH2B1 to mediate their effects in cells. Such insight is critical to our understanding on how growth hormone brings about its well known diverse effects in the body, including body growth and metabolism, and other SH2B1 activating ligands contribute to, prevent and/or alleviate symptoms of a variety of diseases including obesity, various cancers, diabetes, multiple sclerosis, and diseases of the immune system. These studies will provide insight into the role of a multifunctional adapter protein SH2B1 in the function of growth hormone and the many other cytokines, hormones and growth factors (e.g. leptin, insulin, nerve growth factor) that use SH2B1 to mediate their effects in cells. Such insight is critical to our understanding on how growth hormone brings about its well known diverse effects in the body, including body growth and metabolism, and other SH2B1 activating ligands contribute to, prevent and/or alleviate symptoms of a variety of diseases including obesity, various cancers, diabetes, multiple sclerosis, and diseases of the immune system. __SpecificAimsTextDelimiter__ SPECIFIC AIMS A significant recent development is the identification of SH2B1 (also known as SH2-B/PSM) as a candidate human obesity gene ((1-5), S Farooqi, see letter). Patients with deletions on chromosome 16p11.2 that delete SH2B1 or who express one of several SH2B1 coding mutations exhibit hyperphagia, severe early onset obe- sity with disproportionately severe insulin resistance, impaired brain development, and in some cases, short stature. This complex phenotype is similar to that of SH2B1-/- mice (6, 7) and is consistent with defective signal- ing for the multiple hormones and growth factors that use SH2B1 as a signaling protein (8). Together, these findings emphasize the need to know more about the basic cellular functions of SH2B1. We identified SH2B1 as an adapter/scaffolding protein that is recruited to JAK2 in response to growth hormone (GH) binding (Fig 1). GH stimulates SH2B1 phosphorylation by JAK2 and Ser/Thr kinases (9). SH2B1 has been implicated as an activator of JAK2 (10, 11) and as a critical component in GH regulation of the actin cytoskeleton (12, 13), a necessary prerequisite for cellular proliferation, differentiation and migration. While we have gained significant insight into how SH2B1 binds to and regulates JAK2, the mechanism by which it facilitates GH-induced changes in the ac- tin cytoskeleton in mammalian cells remains largely unknown. It is also un- clear what holds SH2B1 in the plasma membrane (pm) so that it is main- tained in close proximity to membrane receptors and the actin cytoskeleton, yet is able to move between such diverse subcellular compartments as the pm, focal adhesions, lamellipodia, cytoplasm and nucleus. Our long-term goal is to delineate the mechanisms by which SH2B1 contributes to the functions of GH. In this way, we hope to gain insight into hitherto unrecognized cellular actions of GH, new functions of SH2B1, and how scaffolding proteins promote movement of complexes among different subcellu- lar locations. In the current proposal, we will build on our past findings to provide insight into the molecular ba- sis for how SH2B1 contributes to the cellular functions of GH. This information will also help us understand at the cellular level how mutations in SH2B1 cause obesity and the other phenotypes that are associated with those mutations. More specifically, we propose to examine the mechanisms which underlie our hypothesis that Fig 1 GH P P P P P P P JAK2 JAK2 PSH2B1P SH2B1P SH2B1 Metabolism Motility Growth nucleus P P P P P P SH2B1 SH2B1 Apoptosis P pSer P pTyr SH2B1 facilitates the formation and/or movement of SH2B1 "signaling complexes" to specific locations in the cell (e.g., pm, lamellipodia, cytoplasm, nucleus) in response to GH. These functions of SH2B1 enhance GH regulation of the actin cytoskeleton, GH induced motility, and GH responses in the nucleus. They are critical to normal human physiology, such that their impairment due to mutation contributes to the dramatic phenotype observed in human patients. The specific aims are as follows: 1. Elucidate the mechanism by which SH2B1 reversibly localizes to the plasma membrane, cytosol and nu- cleus. Our working hypothesis is that phosphorylation of Ser near the polycationic NLS releases SH2B1 from the pm, allowing the NLS to switch from a pm localization signal to a nuclear localization signal. 2. Determine the role of SH2B1 in regulating GH-induced changes in the actin cytoskeleton and cell motility and trafficking of proteins between intracellular compartments. Our working hypothesis is that the polycati- onic NLS in SH2B1 targets SH2B1 to the pm, and that upon GH stimulation, phosphorylation a) releases SH2B1 and allows it to move to specific pm regions, including lamellipodia and ruffles, where it enhances dynamic remodeling of the cytoskeleton through its interactions with actin-binding and/or regulating pro- teins, or b) alters SH2B1 within an existing cytoskeletal structure (focal adhesions), leading to a change in the dynamics of that structure required for GH-induced formation of lamellipodia and cell motility. 3. Determine the functional consequences of mutations in SH2B1 associated with human disease. Our work- ing hypothesis is that human mutations of SH2B1 associated with human obesity impair the function of SH2B1 by altering its folding/stability, subcellular location, or ability to bind to its binding partners. By achieving these aims, we will gain insight into fundamental mechanisms by which GH regulates its diverse physiological functions, including body growth, metabolism, immune responses, aging, and mental well-being. Because SH2B1 is a signaling molecule for multiple hormones, growth factors and cytokines [e.g., insulin (14), leptin [8](15), brain-derived neurotrophic factor (BDNF)(16), nerve growth factor (NGF) (17, 18)] that activate tyro- sine kinases, and both humans and mice with reduced or mutant SH2B1 display multiple phenotypes, the pro- posed studies have the potential to impact many diverse and important fields of study. Thus, our studies may ultimately suggest ways to prevent and/or treat symptoms of numerous diseases including cancers, diabetes and its complications, obesity, various developmental abnormalities, neurological disorders, and immune/ he- matopoietic diseases. Our investigation into the mechanistic basis by which complex, multi-protein based sig- nals are transmitted between membrane-bound receptors and multiple, often remote, sites in the cell will con- tinue to expand our understanding of the critical role that adapter proteins and motifs that regulate cellular loca- tion play in signaling in biological systems.